Recreational Marijuana Marketing and Young Adult Consumer Behavior

SUMMARY/ABSTRACT The past decade in the US marked pivotal changes in the policy and retail environments regarding marijuana (MJ), the most commonly used federally illicit drug, particularly prevalent in young adults and racial and sexual/gender minorities (SGM). Despite controversy regarding recreational MJ, further legalization is likely, and states will continue to struggle with how to implement legislation. Thus, states with legalized recreational MJ provide an opportunity and a need to monitor recreational MJ retail and impact on various subpopulations, as regulatory frameworks for MJ are in their infancy and require additional research given the nuances of MJ retail (e.g., specialty stores, uniquely diverse products, progressive promotional strategies). The overall goal of this research is to inform regulatory efforts to minimize MJ use in vulnerable populations, in states with legalized recreational MJ and those that subsequently legalize it. The immediate objective of this proposal is to examine the recreational MJ market, MJ use, and related perceptions in consumer segments of vulnerable populations, particularly diverse young adults. Our scientific premise builds on literature that indicates that licit drug retail marketing – both brick-and-mortar and online – target vulnerable populations (e.g., racial/ethnic minorities, SGM, young adults) and the consequences of such marketing on substance use in these groups. The MJ retail has largely lacked standardized industry marketing surveillance tools, which have been critical in establishing the impact of tobacco and alcohol retail marketing and informing regulation. This proposal leverages our team’s prior work; we developed surveillance tools to characterize point-of-sale practices (e.g., age verification), product availability, promotional strategies, and product pricing at brick-and-mortar shops and online. Findings indicated several issues with policy compliance (e.g., inconsistent age verification), promotional strategies appealing to young people and minorities, various health claims, and minimal health warnings. In addition, our team has demonstrated the utility of identifying young adults at high-risk for substance use and likely exposure to related marketing by using industry market segmentation based on psychographics (e.g., values, attitudes, lifestyle); the extent to which psychographics vs. sociodemographics inform industry marketing strategies, particularly among vulnerable populations, is not well known. Using a Socioecologic Framework, we aim to: 1) determine whether neighborhood demography is associated with marketing and point-of-sale practices among recreational MJ retailers over time, accounting for policy context; and 2) compare young adult market segments defined by age and minority status vs. psychographics in relation to MJ use, perceptions, access, and advertising exposure in states with differing MJ policy contexts (recreational, medicinal, no legalized MJ policy) over time. This proposal a) is responsive to PA-17-135, addressing a timely public health issue; b) is supported by a strong scientific premise and rationale; c) is highly integrative across aims/data sources; d) leverages robust, replicable methods yet integrates innovative, novel applications; e) prioritizes dissemination and translation to impact public health and regulation; and f) will be executed by uniquely-poised research team and stakeholder advisors.

Public health relevance
PROJECT NARRATIVE The overall goal of this research is to inform regulatory efforts to minimize marijuana (MJ) use in vulnerable populations, in states with legalized recreational MJ and those that subsequently legalize it; the immediate objective of this proposal is to examine the recreational MJ market, MJ use, and related perceptions in market segments of vulnerable populations, particularly diverse young adults. Our scientific premise builds on literature that indicates that licit drug retail marketing – both brick-and-mortar and online – target vulnerable populations (e.g., racial/ethnic minorities, sexual/gender minorities, young adults) and the negative consequences of such retail on substance use in these groups. Based on existing evidence, our central hypothesis is that exposure to MJ retailers and their advertising, advertising strategies targeting specific consumer market segments (defined by key sociodemographics or psychographics), and increased availability of products and promotions may contribute to increased MJ use in such vulnerable populations.